Scalable and Interoperable framework for a clinically diverse and generalizable sepsis Biorepository using Electronic alerts for Recruitment driven by Artificial Intelligence (short title: SIBER-AI)

PROJECT SUMMARY
Sepsis is a major health challenge worldwide that is associated with a significant risk of mortality. The key to
improved outcomes in sepsis is earlier treatment once diagnosed, with delays in therapy being associated with
worse outcomes. Sepsis is a heterogenous disease, and thus despite decades of research focused on various
aspects of sepsis, there still remains much to be learned about the underlying mechanisms that result in
differences in outcomes. The utilization of biorepositories gives investigators the opportunity to study different
mechanisms of disease; however, it is imperative that we collect biospecimens early on in disease and at
different time point in order to understand disease trajectory. Furthermore, there are opportunities within
critical care research to diversify the patient population enrolled in studies in order to investigate disparities that
occur in sepsis. Thus, the need to develop best practices and standard operation procedures are required
that may serve as templates for establishing scalable and generalizable sepsis biorepositories. This proposal
aims to 1) develop an integrated multi-modal clinical, physiologic, volatilomic, and multi-omic biorepository
profile driven by a semi-autonomous screening algorithm to enrich sepsis phenotypes; 2)design and test novel
methods of biospecimen collection among enriched sepsis populations in both ambulance and acute care
hospital environments ; and 3)develop novel approaches to biorepository consent that match the clinical
context of sepsis, maximize representativeness among patients, and enhance trust and engagement among
patients and surrogate decision-makers.

Public health relevance
PROJECT NARRATIVE Sepsis the leading cause of death among critically ill patients in the United States. Despite decades of research on sepsis, there still remains much to be learned regarding the underlying mechanisms of disease. Biorepositories of human biospecimens provide us with the opportunity to better understand sepsis. This application is aimed at developing a screening algorithm and novel consent approach in order to support existing and novel methods of biospecimen collection in sepsis patients.